Metabolic control of extracellular matrix synthesis

PROJECT SUMMARY/ABSTRACT
The extracellular matrix (ECM) is crucial for maintaining the connective tissue in all organs, supporting tissue
homeostasis and repair. When tissue homeostasis is disrupted by wounds or injury, fibroblasts become
activated to help repair the damage and restore tissue structure by producing fibrillar collagens and other ECM
molecules. If fibroblasts produce insufficient collagen, it could lead to nonhealing, chronic wounds. Conversely,
excessive collagen synthesis can lead to fibrosis and impairment of organ function, a major healthcare
challenge. How fibroblasts maintain the intricate balance between underproduction and overproduction of ECM
remains an important yet unresolved question. A key challenge is understanding how fibroblasts regulate the
production of ECM proteins, particularly collagen. An important but often overlooked aspect of ECM production
is that fibroblasts must meet substantial metabolic demands to produce ECM biomass. These metabolic
requirements differ from those for cellular biomass generation during proliferation, including a high demand for
the non-essential amino acids glycine and proline for synthesizing collagens. We and others have
demonstrated that activated fibroblasts upregulate nutrient uptake and metabolic flux into glycine and proline
biosynthesis and that these pathways are required for collagen production. Despite these advances, little is
known about how fibroblasts meet the metabolic demands of ECM synthesis physiologically during tissue
repair. To address this gap, my research program aims to determine the physiological nutrients and metabolic
pathways required for fibroblast ECM synthesis during tissue repair. The central question we will address over
the next five years is: how do fibroblasts meet the nitrogen demands of collagen synthesis to drive tissue repair
while tolerating toxicity from accumulating reduced nitrogen during this process? To answer this question, we
have developed a novel experimental platform to trace nutrients directly into the ECM under physiological
conditions. Leveraging this model, we will: (1) develop a long-term in vivo stable isotope tracing platform to
determine the nitrogen sources for collagen synthesis during tissue repair; (2) understand how ECM synthesis
associated metabolic rewiring allows fibroblasts to tolerate the accumulation of toxic metabolic waste products.
Achieving these goals will provide fundamental insights into cellular metabolism and tissue repair and help lay
the groundwork for strategies to modulate nutrients and their associated metabolic pathways to overcome
healthcare challenges associated with insufficient or excessive ECM synthesis.

Public health relevance
PROJECT NARRATIVE In this research program, we will investigate the nutrients fibroblasts use to meet the metabolic demands of extracellular matrix synthesis during tissue repair. These studies will provide fundamental insights into cellular metabolism and tissue repair, and help lay the groundwork for strategies to address important health care challenges resulting from insufficient or excessive extracellular matrix synthesis.